Metals, critical windows of exposures, epigenetics, and late life cognitive function

PROJECT SUMMARY/ABSTRACT
We propose to study the relation between prenatal and early postnatal exposure to metals—as well as metal
exposures in adulthood—and cognitive function in older age, and the extent to which early life metal exposures
modify the effects of adult exposures. We will also explore whether those exposures and cognitive outcomes are
associated with changes in blood-derived extracellular vesicle (EV) micro RNA expression (miRNA), which could
represent epigenetic mechanisms underlying associations. We will conduct a cohort study among a subset of
participants in the original St. Louis Baby Tooth (SLBT) study who donated their baby teeth in the 1950s and
1960s. Based on our pilot work, we anticipate easily being able to enroll 1,000 former SLBT participants (500
men and 500 women) from whom we will collect blood and toenail samples, and all of whom will have responded
to questionnaires and undergone cognitive testing. Prenatal and early postnatal exposure of the 1,000 to several
metals will be assessed by measuring metals in baby tooth enamel (using laser-ablation inductively coupled
plasma mass spectrometry). Adult metal exposures will be assessed by analyzing a series of toenail clippings
collected roughly once a year. EVs will be isolated from the blood samples and analyzed for EV miRNA
expression levels. The SLBT provides a unique setting that will allow us to have individual-level biomarkers of
early life metal exposures in older adults on whom we can conduct cognitive function testing. This study setting
allows us to have an unprecedented ability to examine whether early life exposures are related to late life
cognitive health—a hypothesis suggested from animal research, but extremely hard to test in humans without
the biomarker of such early exposure that the already collected baby teeth in the SLBT can provide.

Public health relevance
PROJECT NARRATIVE This study will examine the association between prenatal and early childhood metal exposures and late life cognitive function, as well as the role of adult metal exposures and whether early life metal exposures modify the effect of adult exposures. In a subset of a population that donated their baby teeth as children and is now in their 60’s and 70’s, we will analyze metals in those previously collected baby teeth to assess early life exposures, and collect toenail clippings to assess adult metal exposure, and relate those to performance on cognitive tests. We will also assess micro RNA (miRNA) profiles from extracellular vesicles in blood of the adults to examine possible epigenetic mechanisms underlying the investigated associations.